In vivo Multimodal Wide Field of View Multiphoton Microscope for Implantable Medical Devices Research

Project Summary: This request is for funds to purchase a dual-line Bruker 2pPlus multiphoton system equipped
with a resonant and galvanometer-driven scan head and 4 GaAsP detectors. This instrument will be housed
within the Center for Biotechnology and Bioengineering at the University of Pittsburgh School of Engineering.
The mission of the Center is the development of cross-disciplinary research teams by providing laboratory space
and interdisciplinary education programs towards improving the human condition, especially in disease and
injury. A multiphoton microscopy is an essential tool being increasingly used by the investigators at the Center.
Currently, the center has an individual Bruker Ultima IV system being utilized by multiple NIH-funded
investigators. It is heavily used (90-100 hrs/wk), and cannot be upgraded. This application is requesting funds to
purchase a Shared Bruker 2pPlus for all investigators at the Center as well as researchers in adjacent research
facilities. The need for this instrument is demonstrated in this application with several NIH-supported projects
utilizing medical devices, bioengineered technology, and other intervention strategies. To promote cost-
effectiveness in maintenance and upgrades, optimize sharing, and foster a collaborative multidisciplinary
environment, the system will be installed into a current Shared Equipment space at the Center. The Program
Director, Takashi Kozai, Ph.D. is an established innovator in multiphoton microscopy and advanced
neurotechnology, and rodent imaging and will take responsibility for the multiple facets of the instrument's use.
An Advisory Oversight Committee has been formed with guidelines established for appropriate sharing among
the users and by which new users can gain access to and training in the system. Our management scheme is
designed for the optimal use of the system and maximum contribution to the listed projects and to continuously
identify other NIH projects that will benefit from this system. The acquisition of the requested in vivo multiphoton
imaging system will be of enormous value not only to current NIH-funded projects across the University of
Pittsburgh but also to the development of future NIH projects. This is also a key focus of training and research
for the newly funded NIH T32 “Bioengineering in Psychiatry”. The University of Pittsburgh's Swanson School of
Engineering and Department of Bioengineering are fully committed to the support of maintenance, personnel,
space, and resources required for the long-term use of the system.

Public health relevance
Project Narrative: Multiphoton microscopy is becoming an increasingly important method for studying fundamental questions in health, disease, and intervention strategies. Understanding how medical devices and treatments alter cellular events and physiological responses in intact living systems is a powerful way to evaluate and innovate novel intervention strategies. In this application, we request a multiphoton system for imaging medical devices and bioengineered technology in living systems to support many NIH-funded investigators.